Impacts of structural racism on racial and ethnic disparities in perinatal health

ABSTRACT
Women of color have higher rates of poor pregnancy outcomes than non-Hispanic whites in the U.S. For
example, the prevalence of preterm birth is 14.4%, 10.0% and 9.3% among Black, Hispanic, and non-Hispanic
white mothers, respectively. Hispanic and Black women are also at higher risk of maternal morbidities such as
hypertension in pregnancy and gestational diabetes. Along with the compelling evidence of the impact of adverse
perinatal health on the health of a mother and her infant throughout the life course comes high societal and
economic costs. Yet, the etiology of adverse pregnancy outcomes among women of color is not fully explained
by genetics, behavior, or access to care and other factors, including structural racism, likely play a role.
Historically, communities of color have been, and continue to be, burdened by downstream effects of redlining
practices, including housing discrimination and neighborhood segregation. Given the proximity of their
neighborhoods to key sources of air, water, and soil pollution (another consequence of redlining), communities
of color also experience environmental racism, i.e., a disproportionate burden of environmental exposures.
Moreover, women in high-risk communities are subject to spillover stress from disproportionate policing, police
violence, arrests, and incarceration. While there is growing evidence of the impact of structural racism on
perinatal health, findings are equivocal, and research related to the joint impact of multiple forms of structural
racism is lacking. In this application, we will assess the independent effects of structural racism across multiple
domains on racial/ethnic disparities in both maternal morbidity (hypertension in pregnancy and gestational
diabetes) and adverse pregnancy outcomes (low birth weight and preterm birth), explore whether combined
exposures to multiple domains of structural racism enhance disparities, and apply machine learning methods to
identify the key structural racism predictors of adverse perinatal health outcomes. To achieve our aims, we will
construct a retrospective birth cohort of women who delivered infants at major obstetric hospitals in the 3rd largest
county (Harris) in the U.S. (where Houston is located) that will include follow-up throughout a mother’s pregnancy
to the birth of her infant. Our project leverages established partnerships among Baylor College of Medicine,
UTHealth McGovern Medical School, and Texas Southern University through our NIMHD/NIEHS/NICHD P50
Center of Excellence on Environmental Health Disparities Research, focused on reducing environmental health
disparities in maternal and child health, and draws on our collective expertise in environmental and perinatal
epidemiology, women’s health, maternal-fetal medicine, criminal justice, social science, biostatistics, and
bioinformatics. This work is expected to elucidate the contribution of structural racism across multiple domains
on racial/ethnic disparities in several key perinatal health outcomes. Importantly, the results from this study will
also enhance our understanding of the complex interplay and identification of key structural racism drivers of
perinatal health disparities and lay the foundation for future studies to promote interventions.

Public health relevance
Project Narrative Our project entitled “Impacts of structural racism on racial and ethnic disparities in perinatal health” will leverage established partnerships among Baylor College of Medicine, UTHealth McGovern Medical School, and Texas Southern University through our NIMHD/NIEHS/NICHD P50 Center of Excellence on Environmental Health Disparities Research to conduct a retrospective cohort study using electronic health records from major labor and delivery hospitals serving women in the third largest county in the nation (Harris County, Texas) that includes the city of Houston. We will assess the independent effects of structural racism across five domains on racial/ethnic disparities in both maternal morbidity (hypertension in pregnancy and gestational diabetes) and adverse pregnancy outcomes (low birth weight and preterm birth), explore whether combined exposures to multiple domains of structural racism enhance disparities, and apply machine learning methods to identify the key structural racism predictors of adverse perinatal health outcomes.